The Development of Eating Behavior in Infancy: Associations with Behavior, Diet, and Growth to Age 6 years

PROJECT SUMMARY
Eating behaviors are robustly associated with dietary quality and weight gain. Given the relevance of eating
behaviors to health in children and adults, remarkably little is known regarding the development of these
behaviors from infancy, and their continuity (or discontinuity) into childhood. Eating behaviors can be
phenotyped in infancy through rigorous measurement of behavior following exposure to different stimuli under
careful experimental control, though no studies prior to R01HD084163 have phenotyped multiple eating
behaviors objectively in a single longitudinal infant cohort. Eating behavior may be modifiable between infancy
and early childhood, potentially altering any associations with future dietary quality or weight gain. Interventions
that promote adaptive maternal feeding practices have been effective in reducing obesity risk. Intervention
effects might be further strengthened by tailoring to characteristics of the individual child. Identifying
interactions of carefully phenotyped child eating behavior and maternal feeding practices in an observational
cohort study is an important initial step towards future tailored intervention development. The proposed work
will examine for the first time the continuity (or discontinuity) of extensively phenotyped eating behaviors in
infancy, based on novel objective measures and maternal report, to age 5 years. The work will, for the first
time, test whether maternal feeding practices and infant eating behaviors interact to predict child eating
behaviors at age 5 years, as well as dietary quality and BMI at age 6 years. The ABC Baby study
(R01HD084163, 7/1/15-06/30/20) and its ancillary funded studies used novel behavioral protocols to
phenotype eating behavior and maternal feeding practices longitudinally at ages 2 weeks, and 2, 4, 6, 9, and
12 months in a cohort of 286 infants. The current application proposes to follow up with 200 of these children at
ages 5 and 6 years to address the following aims: Aim 1: To test the cross-lagged associations between child
eating behaviors and maternal feeding practices across infancy and age 5 years. We hypothesize that child
eating behaviors in infancy predict child eating behaviors at age 5 years, maternal feeding practices in infancy
predict maternal feeding practices at age 5 years, child eating behaviors in infancy predict maternal feeding
practices at 5 years, and maternal feeding practices in infancy predict child eating behaviors at 5 years. Aim 2:
To test the hypothesis that eating behaviors measured in infancy have direct and indirect (through eating
behaviors at age 5 years) associations with dietary quality and BMI at age 6 years. Aim 3: To test the
hypotheses that maternal feeding practices in infancy moderate associations of infant eating behaviors with
eating behaviors at 5 years, and that maternal feeding practices at 5 years moderate associations of eating
behaviors in infancy with dietary quality and BMI at age 6 years, and moderate associations of eating
behaviors at age 5 years with dietary quality and BMI at age 6 years.

Public health relevance
PROJECT NARRATIVE Eating behavior dimensions, including Food Approach, Food Avoidance, Food-Associated Self-regulation, Food-Associated Affect, and Liking for Sweet, are associated with dietary quality and growth in children and are therefore important to public health. The proposed study has the potential for high impact by establishing the predictive value of infant eating behavior traits and their moderation by maternal feeding practices for future health outcomes. The findings have a high likelihood of providing new intervention targets.